Connecting individual-level environmental exposures to cancer-related outcomes in a shorter-lived natural model system

Following a train derailment in East Palestine, Ohio on February 3, 2023, more than 100,000
gallons of hazardous chemicals consisting of vinyl chloride and other carcinogens were
released into the environment directly and through controlled burn. This disaster offers an
unfortunate opportunity to explore the role of external environmental exposure assessments in
cancer epidemiology.
We propose to use companion dogs as a model system to investigate chemical exposures near
the disaster site and correlations with cancer incidence. Dogs share both indoor and outdoor
environments with their human caretakers and spontaneously acquire many of the same chronic
diseases that occur in humans, including cancer. With their shorter lifespans and accelerated
onset and progression of disease, large numbers of dogs can be recruited in a shorter time
span and provide faster outcomes for longitudinal studies informing human health.
In our parent R01, we are using dogs as a model system for enhancing blood biopsy technology
to improve its accuracy and utility for helping to guide cancer care. We have developed and
validated methods for detecting clonal hematopoiesis (a possible precursor to cancer) and
cancer in dogs through blood biopsies. We also developed a community science platform for
dog cancer research that includes a study of environmental passive samplers in dogs.
Here, we propose to pair blood biopsy technology with passive environmental samplers to
investigate the feasibility and efficacy of using dogs as environmental sentinels to monitor for
health consequences resulting from the train derailment and chemical spill. We will:
Aim 1: Evaluate the relationship between proximity to the train derailment, increases in chemical
exposures to combustion products and health outcomes.
Aim 2: Evaluate the relationship between TD-CP exposures and the occurrence of clonal
hematopoiesis and cancer using blood biopsies.
This collaborative research effort will evaluate the utility of capturing individual-level
environmental exposure information in cancer epidemiology.

Public health relevance
We propose to use dogs as environmental sentinels to investigate chemical exposures and health outcomes near a train derailment in East Palestine, Ohio that releases more than 100,000 gallons of hazardous chemicals. With their shorter lifespans and accelerated onset and progression of disease, dogs could provide faster outcomes for longitudinal studies and potentially demonstrate the utility of individual environmental exposure measurements. We will pair blood biopsy technology with passive environmental samplers and investigate the feasibility and efficacy of using dogs to monitor for health consequences.